Reversible transformation of Anaplasma phagocytophilum using Cre-Lox recombination

Project Summary
Global change, including climate warming and human population increases and movement, has facilitated
range-expansion of arthropod vectors of human pathogens, with mosquitoes, bugs, and ticks increasingly being
reported outside their historic ranges. Concomitantly, there has been an explosive expansion of vector-borne
disease agents, especially obligate intracellular bacteria transmitted by ticks including the recently described
human anaplasmosis agent, Anaplasma phagoctophilum (Ap) that causes a severe and potentially life-
threatening illness. Progress in our understanding of this and related organisms has been hindered by the
inherent difficulties with manipulation of obligate intracellular bacteria in the order Rickettsiales. Moreover,
over 30% of their encoded genes have no matches in the databases, and are thus of unknown function. While
bioinformatics algorithms offer an approach to predict form and function, these predictions are unreliable. At
the same time, uptake of existing genetic systems has been slow, in part due to their limitations. To alleviate this
situation, we propose to employ a modified himar1 transposon-transposase system that enables efficient
replacement of the transposon with another cassette containing a wild-type copy of the mutated gene using
recombinase mediated cassette exchange (RMCE), a well-established molecular technique, to restore gene
function. We will accomplish our planned projects following four specific aims: Aim 1: Generate a collection of
Ap mutants recovered in tick vector and human host cell culture using the himar1 transposon system where the
transposon is designed with flanking mis-matched lox sequences to allow subsequent replacement of the
transposon using RMCE. Aim 2: Determine insertion sites using whole genome sequencing. This will be
facilitated through the use of the Ap-HGE1 isolate for which the genome sequence is available. Aims 1 and 2 will
be carried out during the Phase I (R61) component of the application, and set the stage/provide the mutants for
the subsequent Aims 3 and 4, which will occupy the Phase II (R33) component of the award. Aim 3: Test
infectivity of selected mutants and of genetically “restored” mutants in vitro using multiple tick and mammalian
cell lines, and verify gene knock-out/knock-in using RT-PCR to demonstrate absence and restored presence of
transcripts, and immune-assays to demonstrate absence/restored presence of gene products. Mutants of interest
will be selected for RMCE to restore gene function, and successful RMCE will be verified using site-specific PCR
and Sanger sequencing coupled with assessment of restored phenotype. Aim 4: Test infectivity of selected
mutants and of genetically “restored” mutants in vivo in ticks and mice, including tick transmission studies.

Public health relevance
Project Narrative Obligately intracellular tick-borne disease agents, those that can only replicate inside a vertebrate or tick host cell, are a severe and growing threat to human and animal health world-wide. Studying gene function of bacterial pathogens using mutational analysis in which genes are inactivated by insertion of an interruptive sequence such as a transposon, is an important step towards designing treatments and preventive strategies such as vaccines, but this approach has been very difficult to implement with obligately intracellular bacteria, including those transmitted by ticks. We have pioneered large-scale mutagenesis of tick-borne Anaplasma phagocytophilum in human cells, demonstrated that mutant Rickettsia parkeri are safe and effective vaccinogens, and we now propose to expand on these previous achievements by generating a library of A. phagocytophilum mutants in which the function of mutated genes can be easily restored to verify mutant and wild-type phenotypes, and to test the effect of mutations on mouse infectivity and tick transmissibility.